Novel mechanisms contributing to failure of dolutegravir-containing cART in clinical practice

Millions of people living with HIV (PLWH) will soon receive the integrase strand-transfer inhibitor (INSTI) dolutegravir
(DTG), as the World Health Organization (WHO) now recommends DTG combined with two nucleoside reverse
transcriptase inhibitors (NRTIs) as first- and second-line therapy. This combination therapy demonstrated very high
efficacy in clinical trials and acquired drug resistance was absent (first-line treatment) or very rare (second-line
treatment). It remains to be determined whether this high efficacy and lack of resistance development can be
extrapolated to treatment of non-B subtype viruses in low- and middle-income countries where most PLWH live. Our
long-term goal is to provide a scientific basis for optimal large-scale and long-term treatment of PLWH with DTG. Our
central hypothesis is that novel viral mutations in and outside the integrase gene (with an emphasis on 3’-polypurine
tract changes) contribute to virologic failure with DTG in clinical practice. This hypothesis will be tested by identifying
PLWH failing DTG containing regimens in Brazil which is a model country for large-scale DTG implementation where
various HIV subtypes co-circulate. Subsequently we will perform in-depth in vitro characterizations of novel viral
mutations in and outside integrase gene in an HIV subtype comparative manner. The specific aims of this proposal are:
1) To characterize the pattern of INSTI resistance mutations that emerge during failure of DTG-containing cART in
individuals infected with subtypes C, F, and BF recombinant forms in Brazil. These are the most prevalent non-B
subtypes on the South-American continent. 2) To determine which changes in the 3’-PPT are observed in viruses from
DTG failing individuals. Results of this study will show if this novel resistance pathway contributes to acquired drug
resistance in clinical practice. 3) To determine the phenotypic consequences of mutations identified in specific aims 1
and 2. These studies assess and compare the effect of novel viral mutations on INSTI susceptibility and viral fitness in HIV
subtypes A, B, C, and F in vitro (representing 70% of all infections worldwide), and the molecular mechanism of 3’-PPT
mediated INSTI resistance will be determined. The insights generated with these studies will contribute to a more
effective use of second generation INSTIs in the future.

Public health relevance
In this project we study people living with HIV failing regimens containing the integrase inhibitor dolutegravir in Brazil, a model country for large-scale dolutegravir implementation where various HIV subtypes co-circulate, and then perform in-depth in vitro characterizations of novel viral mutations within and outside the integrase gene in an HIV subtype comparative manner. Results of the proposed studies will help to optimize care of people living with HIV by improving treatment guidelines and drug resistance interpretation algorithms, and may lead to the development of novel diagnostic assays for detecting determinants of integrase inhibitor resistance that lie outside the integrase gene, and novel integrase inhibitors with a higher barrier to drug resistance.